RFA-CE-22-009 Rigorous Evaluation of Community-Level Substance Use and Overdose Prevention Frameworks that Incorporate ACEs-Related Prevention Strategies

PROJECT SUMMARY/ABSTRACT
Early exposure to Adverse Childhood Experiences (ACEs), such as parental substance use, increases the
likelihood of future substance use and drug overdose, resulting in an intergenerational cycle of substance-
related ACEs that can continue indefinitely if left uninterrupted. Community-level interventions may moderate
the relationship between ACEs and substance use by providing an array of family support services and
treatments to reduce disparities and improve reach and service linkages in the community. Although
research suggests that effectively decreasing the prevalence and impact of ACEs and substance use
requires addressing both family- and community-level factors in tandem, there is a critical gap within the
evidence base pertaining to interventions that effectively integrate the two factors to prevent substance use
and ACEs. RTI International and its established partners, the New Jersey Prevention Network and
RWJBarnabas Health, will evaluate an intervention integrating New Jersey’s established, evidence-based
Strengthening Families Program (SFP) with clinically trained, trauma-informed Family Advocates (FAs) who
will assist families in accessing community resources. Specifically, this study will use a Hybrid Type 1
effectiveness-implementation design across 20 New Jersey communities experiencing a disproportionate
burden of substance use and ACEs to address the Research Objective: Conduct rigorous evaluations of
prevention approaches implemented within communities that incorporate efforts to mitigate the
harms of ACEs exposure and prevent future ACEs, while aiming to prevent substance use and
overdose. The study has three aims: (1) use a cluster randomized controlled trial to test effectiveness of the
SFP+FA intervention on substance use, overdose, and ACEs in 10 communities compared with SFP only in
10 communities; (2) conduct a robust process evaluation informed by the Consolidated Framework for
Implementation Research to explore implementation barriers and facilitators; and (3) conduct a cost
evaluation to accurately estimate the costs required to implement SFP and SFP+FA and assess the cost-
effectiveness of SFP+FA relative to SFP alone. Findings will provide a roadmap about the best ways to help
disproportionately affected communities prevent substance use, overdose, and ACEs.

Public health relevance
PROJECT NARRATIVE This study will evaluate a novel intervention that integrates family- and community-level factors to mitigate the harms of Adverse Childhood Experiences (ACEs) exposure and prevent future ACEs while preventing substance use and overdose. We will test (1) whether this intervention increases referrals and linkages to community resources, increases positive family functioning, and reduces youth and parent substance use and ACEs; and (2) if the integrated intervention produces systems-level change vis-à-vis alignment of services and resources. Our findings will provide insight about the best ways to help disproportionately affected communities prevent substance use, overdose, and ACEs.